Addressing Pressure Injury Disparities in Persons with Darkly Pigmented Skin Using Dynamic Tissue Simulations

Project Summary/Abstract
The proposed project focuses on creating a high-fidelity, interactive Pressure Injury (PI) simulation product to
address assessment and treatment disparities of patients with darkly pigmented skin. Significance: Millions of
Americans develop pressure injuries (PIs) each year. PIs cause serious morbidity and excess mortality.
Significant disparities exist as patients with darkly pigmented skin have higher rates of high-stage PIs and a
higher mortality from the wounds. In patients with darkly pigmented skin, identifying developing PIs is nuanced
and challenging leading to them being detected at later stages. Solution: Our proposed product innovatively
leverages recent material advances in 3D Anatomy Printing to comprehensively allow for adjustable skin tones
and representations of all Stages of PI wounds and variations. With our product, students will learn variations
and nuances that occur across skin pigmentation types and how to identify the early development of a PI on
darkly pigmented skin without any visual indications. Specific Aims: In Phase I the following aims are
proposed: 1) Consult with expert advisory panel and perform a final evaluation, 2) Prototype and produce
mannequin materials/mechanical design, and 3) Develop simulation electronics and functionality.

Public health relevance
Project Narrative Pressure Injuries (PIs) are preventable injuries that are attributed to tremendous suffering, represent a significant cost burden on our healthcare system, and are a treatment challenge for healthcare providers. Significant disparities exist as patients with darkly pigmented skin have higher rates of high-stage PIs and a higher mortality from the wounds. Our proposed technology will effectively teach hands-on assessment techniques, nuances, and treatments of PIs in those with darkly pigmented skin.